Does E4orf1 prevent further deterioration in Alzheimer's disease pathology in older mice

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease (AD), is a neurodegenerative disease with associated cognitive decline, dementia
and eventual death. There has been significant advancement in our understanding of AD neuropathology,
however, there are no therapeutic strategies that consistently relieve cognitive symptoms or prevent, cure or
slow its progression. Interestingly, a number of well-designed epidemiological studies have established a link
between Type 2 Diabetes (T2D), a chronic, age-related degenerative disorder and AD, identifying T2D as a
risk factor for developing all cause dementia and dementia attributable to AD. T2D and AD, together with other
neurological conditions, share several clinical and biochemical features. Particularly important amongst these
is impaired insulin signaling, suggesting overlapping pathogenic mechanisms. Hence, an effective treatment
strategy in one disease could have potential value in the other. Several clinical and basic science studies have
shown that anti-diabetic medications can improve cognitive function. Despite promise, none of these strategies
have resulted in improving our understanding or effective treatment options. The long-term goal is to dissect
shared mechanisms between T2D and AD regulating the molecular pathways in AD progression. These
discoveries will facilitate discover effective treatment strategies to prevent AD or its progression. Previous
treatment strategies either act in the periphery or directly in the brain, raising the question if peripheral as well
as central glycemic control needs to be targeted for influencing AD. Therefore, the central hypothesis is that
peripheral hyperinsulinemia contributes to brain insulin resistance and cognitive decline, and that alleviating
hyperinsulinemia in both periphery and brain regions will reduce AD-related molecular deterioration. The
overall objective of this exploratory grant is to harness the ability of adenoviral protein E4orf1 to reduce
peripheral and central hyperinsulinemia and hyperglycemia to attenuate AD progression. The rationale is that
restoring normal insulin action and prevention of further impairment in cognition decline will help identify
mechanisms to offer new therapeutic opportunities. Using the endogenous insulin sparing action of adenoviral
protein E4orf1, the aims will elucidate a previously unidentified therapeutic approach for the effective treatment
of AD. This is a paradigm shift from previously used anti-diabetic approaches for AD treatment and will help
modify currently available therapies or identify new options for prevention and better clinical management of
AD.

Public health relevance
Lay Narrative Alzheimer's disease (AD) is characterized by an inexorable decline in cognitive function and has links with diabetes, as AD patients show impaired insulin function. Most studies focus on preventative treatment strategies with marginal success, therefore, there is an urgent need to better understand the mechanisms during AD pathology. In these exploratory studies, we will examine the role of an adenoviral protein in improving glycemic control and preventing further decline in impaired cognition, which will have significant impact on our understanding of the mechanisms to design better treatment options for AD.